Cancer Research Training and Education Coordination

Program Director/Principal Investigator (Last, First, Middle): Chu, Edward
CANCER RESEARCH TRAINING AND EDUCATION COORDINATION - PROJECT SUMMARY/ABSTRACT
To fulfill the MECC’s mission to train a diverse biomedical workforce, CRTEC is committed to education, training,
and career development activities that promote a better understanding of the origins of cancer and the effective
detection, prevention, and treatment of these diseases. CRTEC fosters education and training across the entire
educational spectrum, including high school students, undergraduates, medical and graduate students,
postgraduate trainees, junior faculty, community physicians, and other healthcare providers. CRTEC activities
are organized into three Specific Aims that provide career enhancement opportunities across the biomedical
training pipeline and develop the next generation of cancer researchers. Aim 1 will coordinate MECC and
institutional programming to educate and inspire high school students, undergraduates, predoctoral and
postdoctoral trainees and junior faculty to pursue careers in cancer research. Key activities include implementing
and expanding MECC high school and undergraduate pipeline programs, which focus on historically
underrepresented populations, expanding MECC’s extramurally funded training grant portfolio and ensuring that
the training pipeline is diverse and inclusive. Aim 2 will support career and professional development activities
across the educational continuum. Key activities include enhancing the mentorship program for junior faculty
through an iterative process of review and refinement, providing mentor (faculty) and mentee (postdoctoral
fellows and graduate students) training, offering career exploration workshops with a focus on alternative careers
in cancer research, and providing training and opportunities for trainees in the communication of cancer research
innovations to audiences in the Bronx catchment area. Aim 3 will track and assess the impact of MECC’s cancer
training and education activities. Key activities will include providing travel awards for trainees to present at
cancer meetings or workshops for skills development, incorporating trainees into the annual MECC retreat and
maintaining a trainee database to follow career progression and outcomes.
OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page

Public health relevance
Program Director/Principal Investigator (Last, First, Middle): Chu, Edward CANCER RESEARCH TRAINING AND EDUCATION COORDINATION - PROJECT NARRATIVE Per PAR-21-321, a Project Narrative is not required for this Component. OMB No. 0925-0001/0002 (Rev. 03/2020 Approved Through 02/28/2023) Page